Diversity Supplement: B Cells Directly Alter Adaptive Plasticity to Support Functional Recovery After Stroke

Our novel data from the past New Investigator R01 award period show post-stroke B cells diapedese into
remote regions (e.g. dentate gyrus) that support motor and cognitive recovery after transient middle cerebral
artery occlusion (tMCAo). B cells can provide neurotrophic support through secretion of both interleukin (IL)-10
and additional neurotrophin(s) to support post-stroke plasticity. The central hypothesis of this R01 renewal is
that a subset of B cells diapedese into brain regions remote from the infarct to provide long-term neurotrophic
support for functional recovery. Brain-derived neurotrophic factor (BDNF) mediates synaptic transmission and
memory formation during health and protects neurons from glutamate-induced excitotoxicity after stroke. BDNF
also mediates B cell egress from bone marrow and can be produced by B cells in response to glutamate
stimulation through the NMDAR subunit GluN2A. Based on our pilot data, we will test: if a subset of post-stroke
B cells, referred to as B cellsBDNF+, upregulate BDNF after encountering glutamate; if B cellsBDNF+ support motor
and cognitive recovery; and if B cell-derived BDNF is impaired in aged females. We will use 4 mos. (“young”)
and 16 mos. (“aged”) female and male mice to test if B cellsBDNF+ support neuronal function, plasticity, motor,
and multi-domain cognitive recovery post-stroke. Aim 1 will test if (1A) post-tMCAo, glutamate binds to B cell
GluN2A to increase BDNF production and drive recovery-linked intracellular Ca2+ signaling that is sex- and
age-dependent. We will (1B) use B cellsNtrk2tm1Ddg/J in vitro to test if the BDNF receptor TrkB is required for
BDNF production and in vitro neuroprotection. Aim 2 will test if B cellsBDNF+ support remote plasticity, motor and
cognitive recovery in a primary motor cortex photothrombosis stroke model. Inducible depletion of (2A) all B
cells or (2B) specific B cell-derived BDNF in young and aged female hCD20TamCre/ BDNFfl/fl mice and littermate
controls will occur either acute (at D0) or delayed (beginning D7 post-stroke). Primary outcomes will include 1)
peri-infarct and contralesional M1 plasticity, 2) improved forelimb precision reaching, and 3) preservation of
Pavlovian stimulus-reinforcer learning on an automated touchscreen task. Aim 3 will test if B cell-derived BDNF
augments long-term motor and cognitive recovery. Aged C57BL/6J female mice will receive tMCAo or sham
surgery and adoptive transfer of B cells that (3A) overexpress BDNF or (3B) lack BDNF, the latter derived from
hCD20TamCre/BDNFfl/fl donor mice, beginning D7 post-stroke. Primary outcomes will include 1) improved
precision skilled reaching, 2) ameliorated hippocampal-specific cognitive deficits tested via touchscreen pattern
separation, and 3) regional ipsi- and contralesional diapedesis of B cells, as determined via whole brain serial
two-photon tomography, that correlates to within-animal magnitude of brain circuit-specific cognitive function
and motor recovery. These studies will confirm an age-dependent loss of a novel subset of B cells, B
cellsBDNF+, in females. They will also confirm that therapeutically targeting B cells can improve motor and
cognitive deficits − a potential treatment supporting plasticity-based recovery after any CNS injury or disease.

Public health relevance
PROJECT NARRATIVE Stroke, the leading cause of long-term adult disability, has no FDA-approved therapeutic treatments to boost long-term recovery in part because we do not understand long-term mechanisms that influence recovery. This research proposes to identify mechanisms of neurotrophin support by B cells, an immune cell subset that moves into uninjured areas of the post-stroke brain to support recovery. These studies will be critical in understanding how the immune system supports neuronal plasticity to improve long-term motor and cognitive recovery after stroke, with critical consideration of age and sex in the response of B cells to stroke.